T cell subsets in inflammatory bowel disease

Summary
The inflammatory bowel diseases (IBD) are chronic, incurable conditions that contribute to significant morbidity
and mortality in the Veteran population. Current therapies are effective long-term in only ~25% of patients with
IBD, suggesting that as yet unknown immune cell subsets may be involved in the initial development and
relapsing-remitting nature of IBD. We propose to elucidate T cell subsets that may play a role in the
pathophysiology of IBD; this work may ultimately lead to new therapeutic targets for IBD.

Public health relevance
The inflammatory bowel diseases (IBD) are chronic, incurable conditions that contribute to significant morbidity and mortality in the Veteran population. Our understanding of the inflammatory bowel diseases remains limited and current therapies are effective long-term in only ~25% of patients with IBD. In this Merit Review proposal, we propose to study T cell subsets that may play a role in the pathophysiology of IBD.